Roles of recycling endosomes in neuronal extracellular vesicle cargo traffic

Project Summary (from original grant)
The goal of this proposal is to understand how cellular membrane trafficking machinery controls the packaging
and release of extracellular vesicle (EV) cargoes from synapses in vivo. EVs are small membrane-bound
vesicles released by numerous cell types including neurons, carrying cargoes critical for signaling and
disease. However, we understand very little about how EV cargo traffic is spatially and temporally regulated
within the polarized and complex morphology of neurons. We have developed tools to track and manipulate
EV traffic at Drosophila presynaptic terminals in vivo, and discovered that flux of cargoes through a plasma
membrane-recycling endosome route determines whether they are locally sorted for packaging and release
in EVs, rather than depleted from synapses by retrograde transport. Recycling endosomes have primarily
been studied in non-neuronal cells, and very little is known about their lifetime, functions, or dynamics at
presynaptic terminals. We do know that recycling endosomes play critical roles in signaling, neuronal
morphogenesis, EV traffic, and synaptic transmission. Understanding and therapeutically intervening in these
important processes will require a deeper knowledge of the mechanisms of neuronal recycling endosome
function. In this proposal, we will elucidate the mechanisms of synaptic EV cargo and recycling endosome
traffic in vivo. To achieve these goals, we will use Drosophila genetics, biochemistry, high-resolution
microscopy, and live cell imaging. 1) We will determine the functions, dynamics, and regulation of different
types of synaptic recycling endosomes. To this end, we will develop new tools and approaches to define and
control functionally distinct recycling compartments at synapses. Using these tools, we will test novel
mechanistic hypotheses for how membrane traffic machinery sorts cargoes at synaptic recycling
compartments. 2) We will determine how EV cargo traffic depends on distinct modes of synaptic endocytosis:
clathrin-mediated endocytosis, which operates under low neuronal activity and activity-dependent bulk
endocytosis, which operates during intense neuronal activity. These experiments will ascertain if EV fate is
determined by different modes of internalization, how recycling endosomes contribute to these functions, and
provide new mechanisms to link activity, endosomal traffic, and EV release. Given the conserved nature of
synaptic membrane trafficking machinery, our findings and tools will lay the foundation for new insights into
EV traffic in many aspects of nervous system function, including in human neurological disease.

Public health relevance
Project Narrative (from Original grant) Neurons can communicate with each other via electrical and chemical signals, as well as membrane-bound packets called extracellular vesicles. These vesicles carry cargo that can contribute to normal brain function, but in neurological disorders including Parkinson’s and Alzheimer’s Diseases, they can also spread toxic proteins throughout the brain. Our research will help us understand how extracellular vesicles are packaged, released and spread in the nervous system, and may identify new strategies to treat a wide variety of neurological diseases.